Mechanisms of Sister Telomere Cohesion and Resolution

Project Summary Telomeres and rDNA are each crucial for the basic cellular functions of chromosome end protection and ribosome biogenesis, respectively. At the same time, they each constitute major repetitive domains of the genome that can contribute to genomic instability. Repetitive sequences pose challenges to the replication machinery that can lead to fork stalling and DNA damage. Damage can be repaired by homology directed recombination and repair using the sister chromatid following replication. Cohesion between sister chromatids is essential for this repair. Cohesion is particularly important for repetitive sequences, to keep them aligned and to prevent recombination with non-­sister chromatids. While it is well established that cohesin rings are required to hold sister chromatids together at the macro level, it is not clear how the more intimate contacts, particularly those required for repetitive DNA, are mediated. Our published work and preliminary data in this proposal indicate that these two essential repetitive domains (telomeres and rDNA) may have a common mechanism for controlling sister chromatid cohesion that is distinct from the rest of the genome. This research project builds on our recent discovery that a) the cohesin ring plays a limited role in telomere cohesion and thus novel proteins and mechanisms are involved and b) rDNA cohesion is governed by the same mechanism as telomeres. In the first part of the grant in Aim 1 we will continue our investigation of telomere cohesion and go deeper into the mechanisms used by the proteins that we have shown are required and identify new proteins. In the second part of the grant in Aim 2 we will break new ground by investigating cohesion of the rDNA arrays. Together these studies will provide insight into how these essential repetitive domains manage the intimate molecular connections that are required for genome integrity and how their dysfunction contributes to genome instability and pathology.

Public health relevance
Project Narrative Telomeres and rDNA constitute major repetitive domains of the human genome that can contribute to genomic instability. Elucidating the basic mechanisms of telomere and rDNA cohesion will provide insights into how their dysfunction contributes to genome instability and pathology.